Multimodal AI for Precise Clinical and Genetic Diagnosis of Congenital Heart Disease

Abstract:
Congenital Heart Disease (CHD) is the most common and life-threatening birth defect, caused by
pathogenic variants in over 400 genes, with hundreds of thousands of Americans affected. Despite up to
90% of cases thought to be due to genetic variants, currently only <30% cases are resolved. Genetic
diagnosis is critical, as it modifies prognosis, management, medical and surgical therapy, and future family
planning.
A large array of data relevant for genetic diagnosis is typically available due to near universal use of
DICOM image formatting for echocardiography, standardized classification language for CHD, wide
electronic medical record (EMR) adoption, and whole genome sequencing. However, only a fraction of
these data are currently being used effectively. The search for pathogenic variants is currently manual,
making it hard to harness valuable information from previously resolved cases. Interpretation of the genome
is limited to only the ~1% that codes for protein. To address these gaps, we will develop a multimodal AI
module that harnesses information from related cases to prioritize genes likely to harbor pathogenic variants
and a variant identification module to identify likely causative variants from whole genome sequencing
data. The gene prioritization and variant identification modules will be co-designed with input from
stakeholders, integrated into an automated process, and validated while addressing key ethical
considerations.
By completing this project, we will harness previously untapped information to automate genetic diagnosis
in CHD, thus enhancing patient outcomes, advancing understanding of CHD, and paving the path toward
wider clinical and genetic applications of multimodal AI.

Public health relevance
Congenital heart disease (CHD) is the most common life-threatening birth defect, yet many affected individuals do not receive a definitive genetic diagnosis despite the strong contribution of genetic factors to disease. This project will develop artificial intelligence tools that integrate clinical, imaging, electronic health record, and genomic data to improve identification of disease-causing genetic variants in CHD. Improved genetic diagnosis has the potential to enhance patient care, guide treatment and family planning, and advance precision medicine approaches for CHD and related disorders.